Structural Racism and Discrimination in Older Men's Health Inequities

Abstract
The health and well-being of older gay men has been greatly shaped by structural forces, namely
discrimination and, for older gay men of color, racism. Their contemporary history and life course have been
defined by exodus from hostile environments and the formation of supportive communities. The overall goal of
this research is to shed light on the extent and the manner in which structural racism and discrimination shapes
older gay men’s health.
This study will assess the relationships among health, stigma, structural racism and discrimination, resources,
and biomarkers of health and aging in older gay men of four racial/ethnic groups— African American, Latinx,
Asian American, and White— and across HIV status. This research is needed because older gay men’s health
fares worse than that of their heterosexual counterparts, their exposure to structural discrimination is higher,
and they have less access to supportive resources than older heterosexual men. Notably, 40 years after we
first faced HIV, we continue to learn about the consequences of HIV, including aging with HIV. Gay men
comprise the majority of older people living with HIV.
Older gay men face unique health risks and protective factors, yet they constitute a very diverse and complex
population. What we know about their health comes from mostly white, well-educated, and convenient
samples. Hence, the need to collect data from diverse and valid samples. This is a cross-sectional study based
on San Francisco Bay Area. Quantitative and Qualitative data will be collected from a sample of 600 older gay
men. We will collect structural, individual, and biological data to test hypotheses regarding the associations
among structural racism and discrimination, resources, and health (e.g., mental health, HIV risk, cognitive
function). Our team is multidisciplinary and includes our community partner, The Elizabeth Taylor 50-Plus
Network (of the San Francisco AIDS Foundation).
This proposal is in response to NIH’s RFA Understanding and Addressing the Impact of Structural Racism and
Discrimination on Minority Health and Health Disparities. It addresses the Office of AIDS Research Strategic
Plan of tackling HIV comorbidities and health disparities. The data and findings from this study are intended to
constitute the baseline for a longitudinal study.

Public health relevance
Public Health Relevance Statement Structural racism and discrimination negatively shape the health of older sexual and racial minority men, including those living with HIV. The manner in which structural racism and discrimination affect the various subgroups within this population (along race, ethnicity and HIV status), is expected to vary, yet it is poorly understood. This proposal is in response to NIH’s funding opportunity “Understanding and Addressing the Impact of Structural Racism and Discrimination on Minority Health and Health Disparities” and attends to the Office of AIDS Research Strategic Plan of addressing HIV comorbidities, complications, and health disparities. The purpose of this study is to assess the relationships among health, structural racism and discrimination, stigma, resources, and biomarkers of health and aging in older men of four ethno-racial groups: African American, Latinx, Asian American, and white— and across HIV status. The findings of this study may help understand how structural, individual, and biological factors differently affect the health of older men and the ways in which prevention efforts may be improved.